On differentiating selective and neutral evolutionary processes

ABSTRACT
At the founding of population genetics in the early 20th century, S. Wright and R.A. Fisher
developed much of the mathematical and conceptual framework underlying the study of
population-level processes dictating variation observed within- and between-species. However,
as evidenced by decades of published interactions, they held strongly differing views regarding
the relative importance of adaptive vs. non-adaptive processes in driving evolution. As pointed
out by J. Crow (2008), these issues were not really resolved, but "rather they were abandoned
in favor of more tractable studies." With the proposal of the Neutral Theory by M. Kimura and T.
Ohta, the relative contribution of stochastic effects, as earlier advocated by S. Wright, received
renewed attention. In the following decades, further theoretical development as well as the
availability of large-scale sequencing data have indeed overwhelmingly justified the important
role of genetic drift. However, subsequent research related to linked, rather than direct, selection
effects have re-ignited previous debates. Namely, whether the large class of strongly and
weakly deleterious variants hypothesized under the Neutral Theory, and their related linked
selection effects (i.e., background selection), are sufficient to explain genome wide patterns of
variation; or whether a more predominant class of beneficial variants, and their related linked
selection effects (i.e., selective sweeps), are required. The primary difficulty in answering this
question stems from our lack of an appropriate neutral null model - that is, a model incorporating
genetic drift as modulated by a realistic demographic history, as well as a realistic distribution of
fitness effects summarizing the pervasive effects of both direct and linked purifying selection.
Without this null model incorporating these evolutionary processes that are certain to be
occurring, it is simply not feasible to quantify the periodic frequency with which adaptive
processes are additionally acting to shape patterns of polymorphism and divergence. Future
work will focus on the necessary theoretical and statistical developments for application to
organisms characterized by small progeny distributions within the context of the Wright-Fisher
model and Kingman coalescent (e.g., humans), as well as large progeny distributions within the
context of the Moran model and multiple-merger coalescent (e.g., viruses). In total, the product
of this research will be a framework for inferring evolutionarily appropriate null models
applicable widely across the tree of life, that will enable the field to directly address this long-
standing and fundamental debate, and to accurately identify genomic targets of adaptation.

Public health relevance
NARRATIVE The relative contributions of adaptive and non-adaptive processes in shaping within and between patterns of sequence variation in natural populations has remained a primary question of interest since the founding of population genetics a century ago. While great advances have been made, a major limiting factor remains the inability to jointly infer the suite of neutral parameters necessary to construct an appropriate null model. Here, I propose a computational approach to achieve this joint inference in organisms characterized both by Wright-Fisher and non-Wright-Fisher patterns of reproduction - an approach which will thus be relevant for commonly studied hosts (e.g., humans) as well as pathogens (e.g., viruses).